Africa Center for Biostatistical Excellence: Expanding biostatistical leadership for HIV/AIDS and TB Research

PROJECT SUMMARY
LMIC: South Africa
Institution: Faculty of Medicine and Health Sciences, Stellenbosch University, Cape Town
Scientific Area: Biostatistics for HIV/AIDS and TB research design and methodology
Africa Center for Biostatistical Excellence: expanding biostatistical leadership for HIV/AIDS and
TB research
This application is in response to the FOA “Fogarty HIV Research Training Program for Low- and Middle-
Income Country Institutions” under the D43 grant mechanism (FOA PAR-19-283) and requests 5 years of
support to expand biostatistics leadership for HIV research design and methodology at Stellenbosch University
in South Africa.
HIV/AIDS and TB remain the highest contributors to the burden of disease in sub-Saharan Africa (SSA). The
COVID-19 disease resulting from infection with the novel SARS-CoV-2 virus poses a threat to the fragile
healthcare system and infrastructure in SSA. In particular, COVID-19 effects on the delivery of care to people
living with HIV/AIDS is likely to reverse gains in care and treatment programs achieved over decades. Data
driven solutions and targeted research and evaluations demand complimentary teams of leaders, including
biostatisticians. There is a huge deficit of doctoral level biostatisticians in the region.
In 2017, we successfully implemented a masters’ level training program in biostatistics for HIV/AIDS research.
Despite shortage in local biostatisticians with advanced training, we mobilized international collaborators to
assist with teaching and student supervision. For sustainability of our training program, the natural
progression is to train local future leaders in biostatistics who will continue the training initiatives and also
provide research leadership to address the myriad of health problems in SSA.
We propose to continue our efforts to bridge the gap in biostatistics capacity in SSA and develop research
leadership at Stellenbosch University and the region at large. The specific objectives of this renewal of the
training grant are to: (1) develop biostatistics leadership through a doctoral training program at Stellenbosch
University; (2) continue building biostatistics capacity through a Masters’ level academic program and expand
our reach using e-learning platforms; (3) consolidate the ACBE as a leader in providing professional
development in biostatistics and data management to support HIV/AIDS research projects and programs
within the SSA region and lead HIV/AIDS and TB research activities.

Public health relevance
PROJECT NARRATIVE LMIC: South Africa Institution: Faculty of Medicine and Health Sciences, Stellenbosch University, Cape Town Scientific Area: Biostatistics for HIV/AIDS and TB research design and methodology Public Health Relevance: Africa Center for Biostatistical Excellence: Expanding biostatistical leadership for HIV/AIDS and TB research The novel coronavirus disease (COVID-19) poses a growing threat to the progress made towards reducing new HIV infections and care of HIV and Tuberculosis infected people in Sub Saharan Africa. Generation of innovative evidence-informed interventions to address these health problems require well trained methodologists. Leaders in biostatistics provide essential skills in study design, data collection, data analysis and data interpretation, however there is a dearth in biostatistics leadership which need to be addressed.